Evaluating the role of hypoleptinemia in impaired counterregulatory responses to hypoglycemia

PROJECT SUMMARY
Hypoglycemic complications are the major barrier to achieving healthy blood glucose levels in persons
with diabetes (PWD). This is largely predicated by a significant knowledge gap regarding how exposure
to well-known risk factors, such as recurrent iatrogenic hypoglycemia, exercise, or alcohol
consumption, leads to the subsequent impairment of the counterregulatory response (CRR) to
hypoglycemia. Thus, clinical interventions aimed at reducing hypoglycemia in PWD are limited to
behavioral modification, such as short-term adjustment of treatment regimens, often at the expense of
decreased glycemic control. To improve outcomes for PWD, truly efficacious treatments for the
prevention of hypoglycemic complications must be developed. This project is designed to develop pre-
clinical data that identifies druggable targets for the prevention of hypoglycemic complications, thus
addressing the significant treatment burden in PWD caused by hypoglycemia. The PI has recently
completed a series of studies that suggest a novel role for leptin signaling in gating the physiological
response to severe hypoglycemia. This work supports our principal hypothesis that stimuli that lower
leptin levels may inhibit the response to severe hypoglycemia by evoking a “pseudostarvation”
phenotype. More critically, this body of work suggests that interventions that prevent the transition to a
“starvation” phenotype could prevent impairment of the CRR. The overarching goal of this project is to
definitively establish the role of hypoleptinemia in the pathophysiological impairment of the CRR while
developing pre-clinical data that identifies druggable targets for the prevention of hypoglycemic
complications. In order to achieve these objectives, the PI has assembled a team of investigators with
extensive expertise in glucose counterregulation, energy homeostasis, and leptin signaling to achieve
the following specific aims: 1) Elucidate the role of hypoleptinemia in altering glucose counterregulation
during hypoglycemia and starvation. 2) Ascertain the mechanisms by which recurrent hypoglycemia
induces hypoleptinemia. 3) Determine whether leptin treatment can prevent impaired hypoglycemic
counterregulation induced by conditions known to increase hypoglycemic complications in PWD, such
as exercise and alcohol consumption. We anticipate that our proposed studies will demonstrate that
hypoleptinemia functionally drives increased susceptibility to hypoglycemia by impairing the CRR in
physiologically and translationally relevant states. If so, these results will not only identify the first
endocrine mechanism driving hypoglycemic risk, but they will also identify a clinically tractable
treatment for the prevention of hypoglycemia.

Public health relevance
PROJECT NARRATIVE Persons with diabetes often experience life-threatening periods of low blood sugar or hypoglycemia. These hypoglycemic episodes make clinical management of blood sugar in diabetes patients challenging. This research seeks to better understand why diabetes patients develop hypoglycemia, and what can be done to prevent it.